Targeting anoctamin 6 to disrupt trogocytosis of cancer-associated fibroblasts

Project Summary
The fibroblastic stroma comprises most of pancreatic adenocarcinoma mass and is remarkably devoid of
functional blood vessels. It has been assumed that the pancreatic cancer cells obtain their essential metabolites,
such as lipids, directly from the interstitial fluid, but we have found that this is not the case. Instead, we present
evidence from our intravital fluorescent LDL particles tracing experiments that PDAC tumor cells derive their
lipids directly from cancer-associated fibroblasts (CAFs). We have discovered that CAFs feed tumor cells lipids
via direct transfer of membranes in a process called trogocytosis (trogo = ‘to gnaw’ or ‘nibble’). We have also
found that anoctamin 6 (ANO6) is a unique phospholipid scramblase expressed in CAFs in both human and
murine PDAC which is critical for trogocytosis and for cancer cell survival. Trogocytosis is executed when cancer
cells and CAFs form synapse-like plasma membranes contacts (Oncosynapses). Within the Oncosynapse,
PDAC cells induce cytosolic calcium influx via Orai channels (Greek, Orai, gatekeepers) resulting in PtdSer
exposure on CAFs. Finally, we have discovered that ANO6 is critical for CAF membrane trogocytosis by cytotoxic
T cells (CTLs) and is highly immunosuppressive. Here, we will test our central hypothesis that ANO6 is a safe
and effective target in PDAC to disrupt delivery of exogenous lipids to cancer cells and reverse resistance to
immunotherapy in three Aims:
Aim 1. How ANO6 activity is regulated in CAF-cancer cell oncosynapse? We will focus on delineating the
signaling mechanism by which cancer cells induce influx of calcium via ORAI channels to the CAF cytosol and
activate ANO6 lipid scrambling, resulting in PtdSer exposure and trogocytosis.
Aim 2. How does blockade of ANO6 prevent CAF trogocytosis and antagonize cancer growth? In this Aim,
we will address the mechanism by which ANO6 functions to promote trogocytosis. Sub-aim 2.1 will test how
ANO6 structure regulates trogocytosis in CAFs and sensitivity to ANO6 inhibitors. In sub-aim 2.2, we will test
blockade of ANO6 in CAFs as a therapeutic strategy to antagonize cancer growth.
Aim 3. Does blocking ANO6 enhance anti-PDAC immunity? We will delineate the role of ANO6 in CAFs as
a regulator of CTL trogocytosis in CAF-imposed immunosuppression. Interference with this pathway should
increase the efficacy of anti-cancer immunotherapies by blocking cholesterol transfer from CAFs to CTLs.
We have assembled a team of experts in cancer biology and lipid metabolism (Astsaturov), calcium signaling
(Soboloff), and immunity (Fuchs) to execute these studies. A successful outcome to these studies will define a
paradigm of combined targeting of ANO6, and membrane lipids donation to reinvigorate CTLs, suppress growth
of PDAC tumors and increase their responses to immunotherapy with groundbreaking ramifications for the
treatment of this intractable malignancy.

Public health relevance
Project Narrative Pancreatic Ductal Adenocarcinoma (PDAC) patients do not respond to therapies because their tumors cells are protected by the cancer-associated fibroblast which provide cancer cells with critical lipid metabolites and protect cancer cells from immune attack. In this proposal, we investigate ANO6, a new drug-amenable fibroblastic cell target to disrupt the tumor-feeding function of fibroblasts and to increase the immunogenicity of pancreatic tumors.